Phase II RCT of High-dose Vitamin D Supplements in Older Adults without Dementia

Project Summary/Abstract
There is mounting evidence that low vitamin D blood levels are associated with increased risk of dementia and
Alzheimer’s disease (AD). There are several mechanisms by which low vitamin D status may promote AD
pathology, including reduced β-amyloid (Aβ) clearance, dysregulation of calcium influx and glutamate-mediated
neurotoxicity. Vitamin D interacts with receptors in the hippocampus and many other brain regions, and has
established antioxidant and anti-inflammatory effects. Recent neuroimaging studies have found that low vitamin
D levels are associated with increased periventricular white matter disease, reduced white matter volume and
larger ventricles. Vitamin D deficiency may also have a toxic effect on brain function independent of Aβ
metabolism. Preliminary studies of serum vitamin D levels in a diverse multi-ethnic cohort (n=382) of the UC
Davis Alzheimer’s Disease Center found a high prevalence of low vitamin D status (61% with levels <20 ng/ml),
which was associated with faster rates of decline on executive function and episodic memory.
This Phase II randomized clinical trial aims to test if supplementation with high dose oral vitamin D will
successfully correct vitamin D insufficiency, compared to treatment with standard (RDA) dose vitamin D in a
diverse community-based elderly cohort. The effect of high-dose vs. standard-dose vitamin D on altering
cognitive trajectories will also be assessed and data will be expected to be used in designing a potential definitive
Phase III trial in elderly groups at risk for dementia. A total of 180 elderly persons with longitudinal biomarkers,
neuropsychological testing and brain MRI scans will be enrolled, with 152 (~50 with MCI, 50 with mild AD and
50 with no cognitive impairment) expected to complete the 3½-year study. One-half of each diagnostic group will
be randomized to treatment with high-dose vitamin D3 (4,000 IU daily) or to standard dose Vitamin D (600 IU
capsule daily + ~200 IU dietary = ~800 IU total/day). Longitudinal MRI analyses will provide an estimate of the
treatment effect size on brain atrophy rate. Vitamin D receptor genotype polymorphisms and their impact on
response to oral supplementation will also be examined. If vitamin D supplementation improves cognitive
outcome, this could have a large impact on the public health, since low vitamin D status is a common, readably
treatable condition which may provide a novel window to prevent dementia and AD. Furthermore, the higher
prevalence of AD and dementia in African Americans and Latinos could be partially attributable to vitamin D
insufficiency.

Public health relevance
PROJECT NARRATIVE Low vitamin D status is associated with increased risk of dementia and Alzheimer's disease (AD), the higher prevalence of these conditions in African Americans and Latinos could be partially attributable to vitamin D insufficiency. This Phase II randomized clinical trial aims to test if supplementation with high dose oral vitamin D (4,000 IU) will successfully correct vitamin D insufficiency and slow cognitive decline in a diverse community-based elderly Alzheimer's disease Center cohort. If vitamin D supplementation improves cognitive outcome, this could have a large impact on the public health, since low vitamin D status is a common, readably treatable condition which may help prevent dementia and AD.